VISION RESEARCH CORE GRANT

PROJECT SUMMARY – OVERALL
This application seeks five years of continued support for an NEI Core Grant that has facilitated the research
efforts of vision scientists at the University of California Davis for the past 25 years. The goal is to enhance vision
science by providing cost-efficient, stable, and shared resources that are not generally available to individual
laboratories. It will enhance collaborations and translational research among a large group of vision scientists at
UC Davis holding 17 Core-eligible NEI R01 grants. It will also facilitate collection of preliminary data for new
grant applications by funded and yet-to-be-funded UC Davis laboratories, and sharing of resources developed
for UC Davis with the vision science community outside of our institution. Building on the existing strengths of
the individual cores while also being responsive to new directions and opportunities in the field, the currently
funded cores have evolved to better serve the needs of our NEI investigators. The proposed cores are: (i)
Software Engineering, (ii) Molecular Construct and Packaging, (iii) Microscopy and Tissue Processing, (iv) Small
Animal Ocular Imaging, and (v) Large Animal. Each core director has one or more NEI R01 grants, and is
supported by talented and skilled technical staff. These five cores provide custom facilities and personnel that
serve the needs of our NEI investigators and their trainees. The administrative structure includes an Executive
Committee comprised of the principal investigator and the core directors, along with regular input from all vision
scientists on campus, and a distinguished group of external advisors. Priorities for use of core facilities have
been carefully honed and made available to all investigators. The administration of UC Davis has been, and
continues to be, exceptionally supportive of vision research on our campus. This is demonstrated by a substantial
increase in the number of vision scientists recruited to our campus, by internal funding of $350,000 as a
supplement to this grant, the planned recruitment of new faculty in vision science, and funding for the Center for
Visual Sciences, which provides a means for unifying our community of vision researchers and fostering
collaborations with an accomplished cohort of biologists on campus and vision scientists at other institutions.

Public health relevance
PROJECT NARRATIVE – OVERALL This Core grant provides shared facilities for an energetic and productive cohort of scientists at the University of California Davis who seek to understand structure and function of the visual system in health and disease. It provides an environment that facilitates collaboration across vision science disciplines and clinical vision science.